Role of BET proteins in neuroinflammation in tauopathy

Tauopathies are a group of neurodegenerative diseases that are characterized pathologically by neuronal loss
and the accumulation of aggregates of the microtubule-associated protein Tau in surviving CNS neurons.
Collectively, these disease, which include progressive supranuclear palsy (PSP), frontotemporal dementia (FTD),
chronic traumatic encephalopathy (CTE) and Alzheimer's disease (AD), are a common and important cause of
progressive neurological disability in veterans. Current treatments only partially mitigate symptoms and do not
alter the course of these diseases; consequently, there is an urgent need for new approaches that address
pathogenic mechanisms and prevent disease progression. Convergent genetic and pathological evidence strongly
suggests that Tau is centrally involved in causing neurodegeneration in these diseases, and there is accumulating
evidence that microglial activation and pathological microglial synaptic pruning in response to Tau accumulation
plays a key role in pathogenesis. However, there is limited understanding of the mechanisms regulating aberrant
functions of microglia in tauopathy and whether this could be targeted by novel therapies. During the current
funding period, we discovered that a chemical inhibitor of bromodomains (protein modules that bind acetylated
lysine residues) rescues both neurological function and neuroinflammation in a novel zebrafish tauopathy model.
By using CRISPR/Cas9 to make zebrafish genetic null mutants, we found that the chemical targets a
bromodomain and extraterminal motif-containing (BET) protein, Brd4, which has previously been implicated
in pro-inflammatory signaling. Building on this work, our overall guiding hypothesis is that: Brd4 is necessary
for microglial activation and synapse elimination in tauopathy and is a valid therapeutic target for treatment
of these diseases. To address this hypothesis directly in vivo, we have crossed our novel zebrafish tauopathy
model with a transgenic line expressing a fluorescent reporter protein in its microglia, allowing direct intravital
microscopic imaging of microglial dynamics in the intact brain in vivo (Aim 1A) and recovery of microglia by
flow cytometry for gene expression analysis (Aim 1B). We will determine how microglial functions and
transcriptional programs are altered in tauopathy and by modulation of Brd4. We will further restore Brd4
expression within microglia of Brd4-null zebrafish to establish whether critical functions of Brd4 in tauopathy
are cell-autonomous to microglia (Aim 1C). We will next determine how Brd4 influences neuronal tauopathy,
oxidative stress and synaptic integrity using intravital imaging and biochemical approaches (Aim 2). Finally, we
will test all available bromodomain inhibitors, including some that have already been used in human clinical
trials, for activity in preventing neurological and neuroinflammatory phenotypes in the zebrafish tauopathy
model (Aim 3A). We will take the most promising candidate into a mammalian tauopathy model to test its
translational potential (Aim 3B). Together, these studies will elucidate the role of Brd4 in tauopathy and provide
unique and innovative translational opportunities for development of Brd4-directed therapeutics.

Public health relevance
Tauopathies are a group of diseases in which accumulation of a brain protein called `Tau' damages brain cells. These diseases, which include Alzheimer's dementia and head injury, are collectively a major cause of chronic disability in veterans. There are currently no effective treatments for tauopathies; medications that prevent disease progression would have a significant and positive impact on veterans' health. To address this challenge, we identified chemicals that prevent deterioration of brain function in a novel animal model of tauopathy. One of these chemicals blocks a type of brain inflammation that is thought to mediate the progression of symptoms in tauopathy. In this project, we will define the precise cellular and molecular mechanisms by which this chemical prevents neurological problems the tauopathy model, and test whether this approach could be exploited to develop an anti-tauopathy medication.